The Upstream Center: Income Interventions to Address the Fundamental Causes of Cancer Inequities

ABSTRACT
Persistently impoverished neighborhoods face ongoing disinvestment, leading to significant
social, environmental, and structural hurdles that impact the health outcomes of their
inhabitants. The persistent poverty in these areas presents obstacles to effective cancer
prevention efforts, stemming from intricate and interconnected factors that hinder prevention at
the personal, healthcare system, and societal levels. Enhancing cancer outcomes in these
regions necessitates innovative, cross-sectoral approaches addressing root causes and social
determinants of health. It requires collaborative research and policymaking endeavors that
involve the affected communities in co-creating solutions.
Our supplementary proposal aims to increase the involvement of the Hmong ethnic minority in
cancer-preventive screenings and broader cancer prevention efforts. This aligns with the
primary focus of the main grant but complements it as there are few projects targeting this
specific community. We seek to boost awareness and knowledge regarding cancer prevention
among Hmong communities in California, particularly those facing persistent poverty, while
encouraging their participation in early detection screenings. We will engage in community
outreach by actively participating in local health fairs and other community events. Additionally,
we will conduct a population assessment to identify any correlations between key social needs
and colorectal cancer prevention measures. In line with the main grant's objectives, our focus
will be on assessing the extent to which basic needs, such as income and access to health-
improving resources like food, transportation, and housing, are met. Furthermore, we plan to
utilize California cancer registries as secondary sources to examine Hmong colorectal cancer
outcomes, particularly in areas marked by persistent poverty.

Public health relevance
PROJECT NARRATIVE This proposal aims to enhance the Hmong ethnic minority involvement in cancer preventative screenings. It seeks to boost awareness and knowledge regarding cancer prevention among Hmong communities in California, particularly those facing persistent poverty, while encouraging their participation in early detection screenings and assessing income intervention such as the earned income tax credit. This proposal for Diversity Supplement will allow Ms. April Vang, under supervision and mentored by Dr. Carvajal-Carmona, to investigate the association between key social needs and colorectal cancer screenings in the California Hmong population.